Development and Pilot RCT of a "Healthy Welcome" Intervention to Increase PrEP Uptake and Adherence Among Migrant Men in Johannesburg

PROJECT SUMMARY/ABSTRACT
Background: South Africa has one of the largest rates of migration on the African continent, largely comprised
of migrant men, who are at high risk of HIV acquisition. Pre-exposure prophylaxis (PrEP) is effective at
preventing HIV. Migrant men face barriers to PrEP use, including lack of PrEP knowledge, stigma at clinics,
and unfamiliarity about health services in new settings. To decrease the incidence of HIV in South Africa,
interventions are needed to promote PrEP use among migrant men in South Africa. The goal of this proposal is
to develop and pilot test a “Healthy Welcome” intervention to support migrant men in starting and adhering to
PrEP by linking them to community pharmacies. Candidate: I am an Internal Medicine physician and an
Associate Scientist at Brigham and Women's Hospital (Harvard Medical School). I am applying for a five-year
K23 Career Development Award to obtain the training and research experience that will allow me to become
an independent investigator at the R01 level and an expert in developing interventions to promote engagement
in HIV services among migrant populations globally. Mentoring: Drs. Ingrid Katz and Jessica Haberer will
serve as my co-primary mentors. Dr. Katz brings expertise in behavioral components of intervention
development and strategies to track hard-to-reach populations in South Africa. Dr. Haberer brings expertise in
PrEP clinical trials, including implementation science, the concept of “Prevention-Effective” (P-E) adherence to
PrEP, and mobile health strategies. Co-mentor Prof. Terris-Prestholt will provide mentorship on discrete choice
experiment (DCE) methodology. Profs. Pascoe and Setswe, South Africa-based co-mentors, will provide
mentorship on local application of DCE methods and behavioral economics (BE) strategies for intervention
development (Pascoe) and community engagement and local implementation (Setswe). Profs. Miot and
Venter, South-Africa based members of my Scientific Advisory Board (SAB), will offer guidance on integrating
my proposed study within an existing Gates-funded project to offer PrEP through community pharmacies in
South Africa and on policy implications of study findings. SAB member Prof. Lurie will offer guidance on
engaging migrant men. SAB member Prof. Thirumurthy will guide me on BE theoretical frameworks. SAB
member Smeaton will provide statistical expertise to guide the pilot randomized controlled trial (RCT).
Training: Training in DCE methodology, BE strategies, and pilot RCTs for PrEP will be achieved through
intensive direct mentorship and coursework. Research: The specific aims are to 1) elicit preferences for PrEP
services among migrant men through a DCE; 2) design a “Healthy Welcome” intervention for migrant men to
promote linkage to pharmacies for PrEP uptake and adherence; and 3) evaluate the feasibility, acceptability,
appropriateness, and fidelity of the intervention through a pilot RCT. I will use this formative research to apply
for an R01-level grant to evaluate the efficacy and effectiveness of the intervention.

Public health relevance
PROJECT NARRATIVE In South Africa, migrant men are at elevated risk of acquiring HIV, and pre-exposure prophylaxis (PrEP) is effective at preventing HIV, but migrant men face barriers to using PrEP, including lack of knowledge and counseling, the opportunity costs of seeking care, and unfamiliarity with health services in a new setting. Pilot data show that migrant men are interested in using PrEP should they be given information and counseling, and if other barriers are addressed, including lost work opportunities as well as the inconveniences and perceived stigma at clinics. This study will 1) elicit preferences for PrEP counseling and service delivery among migrant men through qualitative interviews and a DCE; 2) design a “Healthy Welcome” intervention for migrant men to promote linkage to community pharmacies for PrEP uptake and adherence; and 3) evaluate the feasibility, acceptability, appropriateness, and fidelity of the intervention through a pilot RCT.